Experimental Pathology Laboratory

PROJECT SUMMARY/ABSTRACT
The Experimental Pathology Shared Resource (ExpPath) mission is to provide quality-controlled, consistent,
reliable, and cost-effective services for the morphologic and molecular analyses of tissues impacted by cancer.
ExpPath is crucial to the four Perlmutter Cancer Center (PCC) Research Programs, as it serves as a central
hub in the workflow of tissue-based translational research and is uniquely positioned as a “bridge” between “wet-
bench” research laboratories and the clinic. Ninety-seven (97) members from all four Programs used ExpPath
services during the current funding period (2018-2022), and 124 cancer-related peer-reviewed grants included
ExpPath services. ExpPath is directed by Cynthia Loomis, MD, PhD, an internationally recognized
developmental biology and cancer researcher with >30 years' of experience in leading expertise-intensive
resource laboratories focused on spatial analyses of normal and diseased tissues. She is assisted by a staff of
8 highly trained scientists, including 3 MDs/PhDs, and a New York state certified histotechnology technician.
ExpPath provides standard and highly customized histopathologic services for pre-clinical tumor models and
works closely with the Center for Biospecimen Research and Development (CBRD), which provides
histopathologic services for CAP-certified, IRB-compliant human samples. ExpPath tests and optimizes state-
of-the-art assays on human or animal tissues and has been at the forefront of emerging spatial profiling
technologies. Over the past 5 years, ExpPath has significantly expanded its service portfolio of biomarker assays
and image analysis. Current state-of-the-art technologies available to PCC members include multiplex
RNAscope, high parameter immunostaining (PhenoCycler/CODEX), spatial transcriptomics (Visium and
GeoMx), and neural network-based image analysis software and training (HALO). Implementation of these
cutting-edge technologies requires diverse expertise, so ExpPath collaborates closely with CBRD, The Genome
Technology Center (GTC), The Immune Monitoring Laboratory (IML), The Metabolomics Laboratory
(MBX) and The Microscopy Core Laboratory (MICROS). ExpPath solicits yearly surveys and meets with its
internal advisory board to ensure ongoing alignment with PCC investigator needs. It achieves its mission by
means of four Specific Aims: 1) To assist PCC investigators in the molecular and morphologic characterization
of normal and diseased tissues by providing relevant scientific expertise and technical support, 2) To train
investigators in all aspects of tissue preparation, biomarker detection and analysis, and to facilitate rigor and
reproducibility by standardizing procedures across the institution, 3) To introduce cutting-edge technology and
integrate novel approaches for in situ interrogation of intact tissues and 4) To expedite translational research by
clinical investigators and basic scientists with shared research interests by facilitating multidisciplinary cross-
shared resource collaborations.